Fibrillar polymorphs in human brain tissue

Fibrillar polymorphs in human brain tissue
Project Summary
Alzheimer's disease (AD) is a neurodegenerative disorder defined by the accumulation of protein deposits of Aβ
peptide and tau protein. Progression of AD involves spread of tau deposits, called neurofibrillary tangles, along
well charted anatomical pathways in the brain. Tauopathies such as Pick’s disease, frontotemporal dementia,
progressive supranuclear palsy (and others) are associated with alternate patterns of pathology throughout the
brain with the consequent differences in clinical phenotypes. The structures of fibrillar polymorphs of tau have
been determined at high resolution and there are well-established differences in the dominant isoform/polymorph
of tau associated with each of these diseases. It has been suggested that differences in composition, structure
and post-translational modifications (PTMs) of tau oligomers/fibrils among individuals lead to differences in
bioactivity that impact disease attributes such as age of onset, rate of progression and anatomical distribution of
pathology. In order to test that hypothesis, methods will be used to observe tau in situ, in different brain areas
and at different phases of disease. A central hypothesis of this project is that interrogating the structure of tau
aggregates in the context of intact tissue during disease progression can clarify if homogeneity or heterogeneity
is the predominant feature of tau deposits that contribute to an individual’s Alzheimer phenotype. Advanced
techniques will be used to prepare human brain samples and enable scanning x-ray microdiffraction (XMD) to
map in situ the distribution of structural variations at the molecular level. Mapping the distribution of fibrillar and
non-fibrillar structure within and among tau lesions will provide a measure of the degree to which disease
progression is driven by prion-like spreading and clarify the role of non-fibrillar condensates in seed and fibril
nucleation. Evolution of the structural organization of lesions will be tracked by studies of different regions of the
brain at Braak stage II onward. For each case, independent of disease stage, the entire tau-Braak pathway will
be investigated to detect any pre-fibrillar deposits or alterations in tissue structure that may precede or coincide
with the emergence of fibrillar pathology. Observations in typical AD cases will be compared with analogous
studies of Pick's disease, progressive supranuclear palsy (PSP), FTLD-Tau (Frontotemporal lobar degeneration
with tau pathology with P301L tau mutations) and resilient cases (in which high plaque burden is observed in the
absence of overt clinical dementia). This will define the breadth of variation in fibrillar structure and organization
in these neuropathies and test the hypothesis that disease-specific polymorphs interact with brain tissue in
distinct ways that lead to different anatomical distributions of pathology and variation in disease phenotype.
Correlation of observations across brain regions and at various stages of disease will make possible detection
of patterns in the molecular structure of plaques and tangles, construction of a sequence of events that may
reveal causal relationships and clarify the nature of underlying molecular processes as a basis for identifying
molecular interactions essential to disease progression and thereby susceptible to clinical intervention.

Public health relevance
Narrative: Alzheimer's disease is a neurodegenerative disorder in which deposits of abnormal fibrillar aggregates accompany the spread of neuronal damage during disease progression. A central hypothesis of this project is that the role of these fibrillar aggregates may be clarified by observing them in the context of diseased tissue. To do this, a multidisciplinary team will use methods that generate detailed information on fibril structure and organization while preserving information on their locations across multiple length scales.